Chemoprevention of Electronic Cigarette Promoted Oral Squamous Cell Carcinoma

Cigarette smoking (CS) is a well-established risk factor for oral squamous cell carcinoma (OSCC), the most
common cancer affecting the oral cavity with dismal prognosis even with modern cancer treatment. While
cessation efforts are important, many smokers are unable or unwilling to quit, and smokers after short-term
cessation will still be at high risk for OSCC. Thus chemo-preventive approaches in those with a history of CS
and oral premalignant lesions become attractive.
Introduced as a healthy alternative to CS, e-cigarettes (e-cigs) are currently used by approximately 13 million
U.S. adults (5%). Our team recently revealed that e-cigs accelerated OSCC xenograft growth and lung
metastasis. Importantly, we demonstrated that long-term e-cig exposure, together with 4NQO treatment, induced
OSCC in 40% of p53 conditional knockout mice and pre-malignant lesions in an additional 50% of mice.
The significance of chromatin histone modulation in e-cigs induced carcinogenesis and cancer-related
inflammation, a reversible change with chemo-prevention potential, is being recognized. A recent report revealed
e-cigs reduced histone methylation in gingival mesenchymal stem cells; our group found significant accumulation
of macrophages and T cells in e-cigs promoted OSCC microenvironment; enhanced expression of lysine
demethylase (KDM) 6B and inflammatory genes in e-cigs treated macrophages, reduced by KDM inhibitor.
In this proposal, our objective is to establish a screening system and to identify histone modulation enzymes
critical for e-cig-promoted oncogenes/pro-inflammatory genes and to establish an animal model testing
chemoprevention of e-cigs accelerated OSCC. Our central hypothesis is e-cigs with varied delivery methods
and e-liquid compositions differentially accelerate OSCC carcinogenesis, induce oncogene-specific histone
modulation in tumor cells and inflammatory gene-specific histone modulation in tumor-associated immune cells,
thus providing a model for discovering chemopreventive targets. To translate the histone modulation enzyme
inhibitor into clinical chemopreventive therapy, validation in animal models is necessary. Cox-2 inhibitors are
classic agents for OSCC chemoprevention with proven effect in animal models. However, the chemopreventive
effects of Cox-2 inhibition on e-cig/CS-promoted OSCC in the C57BL/6 K14CreTrp53flo/flo model is unknown.
Aim 1. To evaluate the effects of e-cigs on OSCC carcinogenesis and tumor cell/tumor-associated immune cell
epigenomic/transcriptomic modulation in C57BL/6K14CreTrp53flo/flo mice.
Aim 2. To validate the chemopreventive effects of an anti-inflammatory agent (Cox-2 inhibitor, celecoxib) in e-
cig + 4NQO exposure-induced OSCC in C57BL/6 K14CreTrp53flo/flo mice.
Future Research Plans: This project will form the basis of an R01 application to study epigenetic-based chemo-
preventive approaches targeting e-cig promoted OSCC.

Public health relevance
PROJECT NARRATIVE Cigarette smoking (CS) is a well-established risk factor for oral squamous cell carcinoma (OSCC), a lethal disease with dismal prognosis despite modern cancer treatment. Vaping was introduced as a healthy alternative to CS, but our pilot results indicate OSCC promoting effects of e-cigarettes in an animal model, probably through alteration of the tumor microenvironment. In this proposal, we will evaluate the OSCC promoting effects of e-cigs of varied e-liquid composition and delivery methods, will likely reveal primary tumor- accelerating “culprit(s)” of e-cigs, and will strive to identify potential treatment targets preventing full-blown development of CS/e-cig promoted invasive OSCC.